Leadership to Enhance Aging Research and Innovation in Medical Culture (LEARN-MC)

Project Abstract/Summary
There is currently no known prevention, cure, or effective treatment for Alzheimer’s disease and related
dementia (ADRD) even as the number of people with ADRD is projected to increase dramatically as the
population ages. Policymakers, advocates, clinicians, patients, and caregivers have asked the research
community to improve our understanding of the cultural dynamics surrounding ADRD in order to develop
effective, evidence-based, and sustainable approaches for caring for ADRD-impacted populations. The
premise of this application is that there is a need for increased research capacity to advance our understanding
of culture, aging, and ADRD and help address the challenge presented by the increasing prevalence of
Alzheimer’s and related dementias.
This application for an Academic Leadership Award is entitled Leadership to Enhance Aging Research and
iNnovation in Medical Culture (LEARN-MC). It aims to enhance the capacity of the University of California San
Francisco (UCSF) to conduct research on aging and medical culture in the context of ADRD. LEARN-MC will
be based in the UCSF Medical Cultures Lab (MCL). It reflects the PI’s training in sociology of culture and
ethnography, his research track record on medical culture, and his experience developing educational and
training programs. LEARN-MC will build on and expand on existing relationships with multiple communities
conducting ADRD research at UCSF including the Departments of Neurology and Surgery, Divisions of
Geriatrics and Palliative Medicine, and the Global Brain Health Institute. LEARN-MC has three specific aims.
Aim 1: Create and maintain a resource library that synthesizes scholarship on medical culture, aging, and
ADRD from anthropology, geriatrics, gerontology, sociology, and related fields.
Aim 2: Develop courses on medical culture, ADRD, and aging to be taught in coordination with existing UCSF
teaching and training programs to learners at diverse career stages.
Aim 3: Establish the Medical Cultures Lab (MCL) as a center of excellence for research on medical culture,
aging, and ADRD. Expand MCL’s role as a mentorship hub for aging and ADRD research at UCSF. Use public
events and social media to establish MCL as a thought leader among policymakers, healthcare professionals,
and the lay public.

Public health relevance
Project Narrative There is currently no known prevention, cure, or effective treatment for Alzheimer’s disease and related dementia (ADRD) even as the number of people with ADRD is projected to increase dramatically as the population ages. Given these circumstances, policymakers, advocates, clinicians, patients, and caregivers have asked researchers to improve our understanding of the social and cultural dynamics of ADRD in order to develop effective, evidence-based, and sustainable approaches for caring for ADRD-impacted populations. This project develops research resources at the University of California San Francisco that address the need to advance research on the social and cultural dimensions of aging and ADRD.